IMMUNOLOGICAL INTERVENTION IN NEWLY DIAGNOSED IDDM

The purpose of this study is to determine if patients with newly diagnosed diabetes can retain beta cell function using immunosuppression and tight glycemic control in a randomized and blinded fashion.